Interdisciplinary Research Training in Otolaryngology

Abstract: Health problems related to our subspecialty require multidisciplinary approaches for understanding
and treating hearing and communication disorders. Advancing the scientific foundation of otolaryngology requires
well-trained investigative teams with diverse skills and backgrounds in basic and clinical science. A new
integrated training program for Otolaryngology-Head and Neck Surgery residents in basic, translational, and/or
clinical sciences related to otolaryngology is proposed based in the Department of Otolaryngology-Head and
Neck Surgery at the University Miami Miller School of Medicine (UMMSM). The training program's mission is
to address these needs by supporting research opportunities in the disciplines related to otolaryngology, providing
strong curricula in an integrative framework, with an interdisciplinary research culture emphasizing mentoring,
academic advancement, grantsmanship, diversity outreach, responsible and ethical conduct of research, and
productivity. The Specific Aims of the IRTO are to: 1) Provide research experience with mentors conducting
basic, clinical, or translational research in diseases and conditions related to hearing and communication disorders;
2) Provide core and elective didactic opportunities to ensure trainees acquire in-depth knowledge of relevant
basic, clinical, and translational research techniques; and 3) Provide curricula, seminars, workshops, and tutorials
focusing on topics related to professional development skills. This program is supported by a highly collaborative
group of mentors who direct active, NIDCD funded research programs; opportunities for interdisciplinary
research collaboration and specialized training in a broad spectrum of research fields relevant to hearing and
communication disorders; and an exceptional institutional infrastructure and research culture provided by
multiple departments and colleges. A history and record of interdepartmental collaborations and collegiality
among researchers in disciplines related to otolaryngology is a key factor for long-term success for our training
program. Equally important is the long-standing culture of support, value, and enthusiasm for research training
by the leadership in the Department and the institution. Moreover, we have successfully obtained a new ACGME
approved 6-year research track position. We aim to provide the scientific training, as well as communication and
administrative skills to enable our graduates to compete successfully for individual NIDCD-sponsored research
awards and eventually become creative contributors to the future of otolaryngology.

Public health relevance
PROJECT NARRATIVE This grant supports a new integrated training program for Otolaryngology residents based in the Department of Otolaryngology-Head and Neck Surgery at the University Miami Miller School of Medicine. There is a current and growing public health need for well-trained physician scientists in otolaryngology to increase the science knowledge base and improve clinical care of patients. The goal of this unique training program is to provide mentored research opportunities in the disciplines related to otolaryngology and communication health, and the tools to acquire the necessary training to become physician-scientists.